Investigating PHGDH deficiency inborn error metabolism in vitro and in vivo using gene regulation and metabolic tracing approaches

Project Summary and Abstract
Inborn errors of metabolism (IEMs) are a diverse group of over 1,000 congenital disorders caused by
enzymatic mutation, the vast majority of which prominently affect the nervous system. Phosphoglycerate
dehydrogenase (PHGDH) deficiency is a rare IEM caused by loss-of-function mutations in PHGDH, the rate-
limiting enzyme in the de novo serine biosynthesis pathway. PHGDH deficiency presents with a clinically
heterogeneous spectrum ranging from lethal neonatal Neu-Laxova Syndrome to nonlethal infantile-onset
manifestations. While it is understood that PHGDH loss leads to serine and glycine depletion, the mechanisms
linking enzyme dysfunction to nervous system phenotypes remain poorly defined. This project investigates how
PHGDH loss disrupts metabolic homeostasis during nervous system development by disentangling its dual
effects on serine-driven one-carbon, and central carbon metabolism. Preliminary data using [U-13C]glucose
tracing in patient-derived PHGDH-deficient cells reveal not only reduced serine synthesis, but also increased
pyruvate synthesis and TCA cycle turnover, potentially exacerbating oxidative stress through reactive oxygen
species (ROS) overproduction. We hypothesize PHGDH deficiency not only inhibits serine/glycine synthesis,
and also increases TCA cycle turnover, predisposing cells to oxidative damage while simultaneously driving
global dysregulation of energy metabolism. In Aim 1, we will use inducible PHGDH expression systems in
patient-derived fibroblast cell lines and [13C] tracers to define how varying PHGDH levels alter metabolic flux
and ROS generation, and test interventions that buffer oxidative stress. In Aim 2, we will characterize the
developmental consequences of PHGDH loss in newly developed humanized PHGDH deficiency mouse
models. We will leverage spatial metabolic imaging and advanced microscopy to characterize the metabolic
functions of PHGDH during nervous system development. Lastly, we will test exogenous, gestational serine
supplementation strategies to assess tissue-specific metabolic vulnerability and embryonic lethality rescue in
development. This work will provide fundamental insights into how PHGDH loss causes metabolic pathway
disruptions leading to nervous system developmental defects. Our work will establish a framework for applying
in vitro and in vivo targeted metabolic tracer and gene regulation approaches to study and potentially treat
PHGDH deficiency and other IEMs. This proposal comprises of a rigorous and reproducible research strategy
and comprehensive training plan that will prepare me to be an independent principal investigator at a tier 1
research institute. This research project will incorporate training in mass spectrometry, isotope tracer analysis,
gene regulation, and molecular genetics. The University of Florida, in combination with the exceptional joint
mentorship of Dr. Matthew Merritt and Dr. Eric Wang, provides an outstanding research environment that will
enable my professional growth and completion of this proposed research.

Public health relevance
Project Narrative PHGDH deficiency is a rare inborn error of metabolism causing profound neurological phenotypes, due to loss of function in PHGDH, the rate limiting enzyme for de novo serine biosynthesis. The metabolic mechanisms linking PHGDH loss to neurodevelopmental defects remain poorly understood due to the downstream biochemical pathway complexities of serine metabolism. This proposal will leverage newly developed PHGDH deficiency cell systems and mouse models, along with [13C] metabolic tracer assays, to uncover mechanisms of PHGDH metabolic dysregulation that lead to nervous system dysfunction.